Cellular Protein Involved in Trafficking of HIV-1

PROJECT ABSTRACT (provided by applicant): Tsg101, a component of ESCRT-I (endosomal
sorting complex required for transport-I), is required for budding of infectious HIV and several
other human pathogens. A proline-rich sequence, PTAP, in the viral-encoded structural precursor
polyprotein, Gag, recruits the cellular factor to virus assembly sites on the plasma membrane by
interacting with a PTAP-binding pocket in the Tsg101 N-terminal UEV [ubiquitin (Ub) E2 variant]
domain. The UEV domain also binds Ub, however, the role of Ub in budding and the relationship
of UEV Ub-binding to the PTAP-mediated recruitment of the ESCRT machinery is not clear.
Recently, using small molecules identified by high-throughput screening of a library for known
drugs capable of binding the UEV, we found agents that inhibit HIV-1 budding by disrupting Ub-
binding at the known pocket in the UEV without disturbing the PTAP-binding pocket. Our NMR
studies identified an additional Ub-binding site in the Tsg101 UEV domain and demonstrate that
the domain is capable of binding di-Ub moieties previously shown to participate in both endocytic
trafficking and budding. This application proposes to use the agents, mutagenesis and structural
analysis to define the mechanism by which the original and newly identified UEV Ub-binding sites
facilitate the budding process through achievement of 3 goals. The goal of AIM 1 is structure-
function analysis of the UEV-Ub complex employing site-directed mutagenesis and small
molecule probes. As we and others find that, while necessary, PT/SAP-mediated recruitment of
Tsg101 alone is not sufficient for budding, the goal of AIM 2 is to test the hypothesis that the
Tsg101 Ub- binding function is required in conjunction with the PTAP-binding function for efficient
recruitment of the protein to the plasma membrane. The goal of AIM 3 is to determine whether
the Tsg101 Ub-binding function is important for trafficking pathways where Tsg101 is not directly
engaged by a viral structural protein, i.e., pathways facilitated by the ESCRT adaptors Alix and
Nedd4. It is well-established that HIV utilizes alternative budding pathways when Gag interaction
with Tsg101 is disrupted: It is therefore important to understand if the required Tsg101-Ub binding
function is redundant. Collectively, the proposed studies will provide mechanistic understanding
of how Tsg101 facilitates HIV-1 Gag trafficking and virus budding and possibly also reveal new
targets for anti-viral drug development.

Public health relevance
PROJECT NARRATIVE The Acquired Immunodeficiency Syndrome (AIDS) pandemic and its causative agent, the human immunodeficiency virus (HIV), continue to afflict ~30 million people globally and within the United States, with >4 million new infections arising each year {~25% in the United States; based on estimates from the World Health Organization (WHO) and the US Centers for Disease Control and Prevention (CDC)}. This application proposes a basic science investigation of HIV-1 protein trafficking, assembly and budding using as probes anti-HIV compounds initially identified in a screen for inhibitors targeting components of the host ESCRT (endosomal sorting complex required for transport) machinery in conjunction with structural analysis and tools of molecular genetics, biochemistry and cell biology. It is anticipated that employing the probes will reveal new mechanistic understanding of the ESCRT machinery that is critical for virus formation and also uncover targets in the budding pathway with potential for anti-virus drug development.